Development and Applications of Unnatural Organisms with a 21 Amino Acid Genetic Code

PROJECT SUMMARY/ABSTRACT

In most organisms, the genetic code, consisting of 64 triplets of nucleotides, encodes 20 amino acid building
blocks used in the synthesis of proteins. The overall goal of the PI’s research program is to develop
interdisciplinary tools to reprogram the genetic code to precisely probe and manipulate biological systems.
Central to reprogramming the genetic code is our ability to add noncanonical amino acids (ncAAs) to proteins of
interest. The overall goal of this proposal is to develop cells able to biosynthesize and utilize ncAAs and explore
the utility or these unnatural organisms in protein evolution and therapy development. To achieve this goal, the
first research direction will focus on the generation of completely autonomous organisms with a variety of 21st
amino acids. The prokaryotic and eukaryotic cells with the 21st amino acid will harbor a biosynthetic pathway and
a bioorthogonal aminoacyl-­tRNA synthetase (aaRS)/tRNA pair for the new amino acid building block. The
biosynthesis pathway of ncAAs will be obtained from other species or via metabolic repurposing. To site-­
specifically incorporate these ncAAs into proteins, we will evolve bioorthogonal aaRS/tRNA pairs and add them
to the cells. The resulting organisms with a 21st amino acids will allow for the evolution of proteins with novel
activities as well as the development of new therapies. To evolve novel or enhanced enzyme activity not
accessible by the 20 canonical amino acids, a library of ncAA-­containing enzyme mutants will be generated in
the unnatural organisms and subjected to a fluorescence-­activated cell sorting (FACS)-­based or survival
selection. The evolved ncAA-­dependent enzymes can be used to prevent the unintended proliferation of
genetically modified organisms or to prepare autotrophic vaccines. Next, we will explore the utility of these
unnatural organisms with additional protein building blocks for therapeutic development. The prokaryotic and
eukaryotic cells able to biosynthesize and utilize amino acids with bioorthogonal handles will be used to produce
antibody variants with optimized therapeutic efficacy. Engineered immune cells with additional building blocks
will allow for the redirection of the specificity of chimeric antigen receptor (CAR)-­immune cells, thus providing a
new design strategy for switchable CAR-­immune cells. Our efforts in this project will yield a collection of
organisms with additional amino acids building blocks, and will result in versatile platforms for ncAA-­based
protein evolution or therapeutic proteins that could revolutionize modern medicine.

Public health relevance
PROJECT NARRATIVE In this proposal, we will create unnatural organisms able to biosynthesize additional amino acid building blocks and use them for protein translation. Cells with 21 amino acid genetic code will be able to generate proteins with novel structures and functions for biochemical and therapeutic applications. The utility of this approach will be demonstrated by preparing novel antibody conjugates and creating switchable chimeric antigen receptor (CAR)- immune cells, thus providing a new design strategy for next- generation medicines.